Unite 2 Fight Paralysis Annual Science and Advocacy Symposium

Project Summary/Abstract
The goal of this application is to support additional efforts to enhance the diversity, equity, and inclusion of
participants for the Unite 2 Fight Paralysis (U2FP) Annual Science and Advocacy Symposium, to be held in
Atlanta, GA in October of 2024. The overarching goal of the Symposium is to accelerate the development,
translation, and implementation of novel treatments for spinal cord injury (SCI). The Symposium aims to build
essential collaborations that are crucial for driving the SCI field forward and towards meaningful change. SCI
presents a significant public health challenge, with life-altering consequences and limited therapeutic
interventions. The Symposium addresses this challenge by bringing together diverse stakeholders to confront
the complexities of SCI research and treatment development. Recognizing the underrepresentation of certain
groups, the application outlines strategic aims to enhance diversity, equity, and inclusion. These include
providing travel awards for trainees from underrepresented groups and conducting outreach activities to invite
individuals from diverse backgrounds, underrepresented groups, and women. To enrich the symposium
experience, innovative approaches are proposed. Discussion sessions led by persons with lived-experience in
SCI (SCI PLEX), coupled with a pre-Symposium workshop on ways to enhance equitable scientific
communications between diverse stakeholders, aim to deepen understanding and address challenges in
delivering restorative treatments for paralysis. The Symposium plans to exclusively feature trainee
presentations in poster and short communication sessions, paired with SCI lived-experience consultants for
guidance on audience engagement. In summary, the U2FP Symposium plans to create a dynamic and
inclusive space for stakeholders, advancing SCI research through collaboration, diverse perspectives, and
improved scientific communication. With aims to enhance diversity and empower participants, the Symposium
stands as a pivotal event in the pursuit of effective treatments and cures for spinal cord injury.

Public health relevance
Project Narrative The Unite 2 Fight Paralysis Annual Science & Advocacy Symposium, in collaboration with Emory University’s Emory Translational Neurotrauma Research Center (ENTiRe), brings together diverse stakeholders, including researchers, clinicians, investors, and persons with lived-experience in SCI (PLEX SCI) with the aim of accelerating the development, translation, and implementation of novel treatments for spinal cord injury (SCI). The activities planned under this award included 20 travel awards for trainees and participants who identify as from underrepresented groups as well as outreach activities to encourage diverse participation, inclusion, and engagement.